Khulani Siphile Siphuhle Training Program in South Africa (KiSS-TP)

Project Summary/Abstract
Sexual and gender minorities are marginalized in South Africa with limited access to health care or opportunities
to take part in research especially concerning their health disparities. This supplemental research training
program aims to build on the parent award, the Khulani Siphile Siphuhle Training Program (KiSS-TP), to improve
the research capacity of young HIV researchers, with a focus on sexual and gender minorities. Improving the
skills and experience of sexual and gender minorities in research will enable them to amplify their voices and
address the health needs of this vulnerable population.
The KiSS-TP is based at the Desmond Tutu Health Foundation (DTHF) Eastern Cape site. The DTHF is a
renowned non-profit research organization affiliated to the University of Cape Town, based in Cape Town, South
Africa. For this supplementary training program, the KiSS-TP will collaborate with the DTHF LGBT+ Health
Division at the Groote Schuur Hospital Clinical Research Site in Cape Town. The DTHF LGBT+ Health Division
plays a vital role in promoting equitable access to healthcare for LGBTQI+ communities through research,
community engagement, and advocacy.
In line with their commitment to empowering LGBTQI+ individuals and communities, the DTHF LGBT+ Health
Division will provide a research training program for early career LGBTQI+ health researchers. This program,
building on the KiSS-TP, aims to enhance research capacity while addressing health disparities and improving
health outcomes for sexual and gender minorities. Trainees will be selected at both the undergraduate and
postgraduate level mainly from historically disadvantaged institutions (HDIs) in South Africa. Preference will be
given to LGBTQI+ persons who are multiply marginalized and/or trans and gender diverse. The training program
will involve a mentored research project which will identify barriers to accessing HIV services and gender-
affirming care for transgender populations in South Africa. Trainees will gain experience in qualitative and
quantitative research methods, including surveys and focus group discussions. They will participate in all phases
of the research process, receive mentoring from experienced LGBTQI+ researchers, and have access to
educational resources, seminars, and community outreach activities. The ultimate goal is to nurture a diverse
and inclusive research environment and develop the next generation of LGBTQI+ health researchers.

Public health relevance
Project Narrative This supplemental research training program to the Khulani Siphile Siphuhle Training Program (KiSS-TP) based at Desmond Tutu Health Foundation (DTHF) in South Africa aims to build the research capacity of young LGBTQI+ individuals and empower them to address health disparities in their communities. The program collaborates with the LGBT+ Health Division at the DTHF Groote Schuur Hospital Clinical Research Site and will provide trainees with the opportunity to participate in a mentored research project examining access to HIV services and gender-affirming care for transgender populations in South Africa. This supplementary program aims to select LGBTQI+ trainees from historically disadvantaged institutions (HDIs) and create an inclusive research environment through which their skills as the next generation of LGBTQI+ researchers can grow.